PREDICTION OF HYDROGEN EXCHANGE PROTECTION FACTORS FOR RIBONUCLEASE H

The COREX algorithm has been used to predict the residue stability constants and hydrogen exchange protection factors for RNase H. Comparison with experimentally observed values reveals good agreement thus providing access to the ensemble of intermediates present under native conditions.